The Syracuse University-Summer Training in Alcohol Research (SU-STAR) Program

A strong scientific workforce is essential for fostering innovation, advancing research, and
maintaining high-quality learning and work environments. Undergraduate research experiences,
such as summer research programs, have been shown to enhance learning skills, career
ambitions, STEM degree completion, and progression to graduate studies. The Summer Training
in Alcohol and Health Research – Undergraduate (STAHR-U) program aims to: (1) recruit an
annual cohort of five to seven undergraduate students nationwide who demonstrate academic
potential and a strong interest in alcohol and health science research, as well as in pursuing
graduate studies in related fields; (2) provide participants with a rigorous eight-week research
internship and enrichment activities; (3) conduct ongoing evaluations during the summer program
and follow-ups to assess recruitment, retention, and educational and career outcomes; and (4)
disseminate program information and materials to students, academic institutions, and the wider
scientific community. Ultimately, this program will contribute to the growth of the future health
research workforce and strengthen alcohol, addiction, and related health sciences.

Public health relevance
The Summer Training in Alcohol and Health Research – Undergraduate (STAHR-U) program seeks to promote engagement in health sciences by increasing undergraduate participation in alcohol, addiction, and related research. Scholars gain hands-on experience under the close mentorship of a faculty mentor and a graduate student or postdoctoral co-mentor, supported by professional development seminars and enrichment activities that prepare them for graduate studies and careers in health science. Ultimately, STAHR-U aims to reinforce the pipeline of future researchers in alcohol and addiction sciences.